Development of a patient-derived tumoroid culture system to explore novel medical treatments for refractory prolactinomas

ABSTRACT
Prolactinomas (PRL-omas), the most common secreting pituitary tumors, frequently cause
hypogonadism and subfertility. Although dopamine agonist therapy often works well initially and 1/3 of patients
experience long-term remission after 2 years of therapy, 1/3 of patients require long-term D2 agonist therapy to
maintain normal PRL levels and a further 1/3 of patients are either refractory to DA therapy or intolerant of their
side effects. Although surgical resection can be offered in some, remission rates in large locally invasive
tumors is <50%. Translational research has been hampered by the lack of any human PRL-oma cell models.
Using current methodologies, human PRL-oma cultures only survive for 7-10 days in vitro. There is an urgent
unmet need for establishment of a human PRL-secreting tumor model that retains its highly differentiated
phenotype and allows sufficient long-term expandability of cells for use in preclinical translational research and
development of novel treatment options. We compared the global transcriptome landscape in consecutive
passages from two human prolactin-secreting pituitary tumor primary cultures using bulk RNA-seq to
understand the molecular events leading to loss of hormone secretion during in vitro human prolactinoma
culture. As pituitary tumor cells lost hormone secretion, we observed a reduction in angiogenesis, survival
signals and immune responses in parallel with increased collagen catabolism, cell adhesion and extracellular
matrix organization. Guided by these findings, we developed a unique 3-dimensional (3D) PRL-oma culture
system and for the first time, we have generated long-term (> 6 months) expandible PRL-secreting 3D human
pituitary tumor cultures (>6 months).
In the first of two aims, we will use our unique patient-derived 3D PRL-oma culture model in a high
throughput screen to identify small molecule inhibitors of PRL secretion and proliferation. We have already
demonstrated the feasability of this approach and identified a compound of interest in a pilot screen and now
wish to conduct an expanded HTS to identify novel therapies for patients with refractory PRL-omas. Our
primary screen will include pharmacological validation and repurposing-, targeted-, lead-like- and diverse-
libraries. Initial hits will be selected using robust z-score statistics and transitioned to aim 2 for further
development. Aim 2 will employ a cascade of follow-up assays to validate potential hit compounds. These will
include dose-response curves in both rat and human PRL-oma cells, assessment and exclusion of non-specific
overly toxic compounds. And tests of specificity on hormone secretion in various murine and human
neuroendocrine tumors. Additionally, in-silica target prediction will be combined with RNA-seq transcriptome
profiling to segregate drug target pathways and deconvolute the MOA of resultant hits. Finally, potential actions
of hits on identified pathway targets will be corroborated by pathway disruption using short hairpin RNA
(shRNA) and CRISPR libraries in both rat and human PRL-omas to define a group of first-in-class hits.

Public health relevance
PROJECT NARRATIVE Hyperprolactinemia due to prolactin-secreting pituitary tumors frequently affects both the central and peripheral reproductive system, leading to hypogonadism and subfertility. Translational research has been limited by lack of pituitary tumor models. We have developed a unique 3-dimensional (3D) pituitary tumoroid culture system that can maintain differentiated prolactin-secreting pituitary tumor cells as a preclinical model for drug discovery.